AEROSOLIZED RIBAVIRIN VS PLACEBO IN ACUTE RESPIRATORY SYNCYTIAL VIRUS

Determine benefit from ribavirin inhalation on hospitalized infants with lower respiratory tract disease caused by RSV compared to an untreated control group.